REFEEDING FASTED SUBJECTS AND 24-HOUR GH SECRETORY PROFILE--GH RESPONSE TO GHRP

Determine whether 24 hours of refeeding a balanced isocaloric diet to subjects fasted for 1 day will decrease growth hormone secretion to control levels. This study will also determine the effects of fasting and refeeding on the GH response to growth hormone releasing peptide. each subject will serve as his own control. Blood samples for GH will be obtained at 5 minute intervals on each study day.